HYPERTROPHIC CARDIOMYOPATHY &DISPROPORTIONATE SEPTAL HYPERTROPHY IN NEWBORN

As echocardiographic study will be conducted prospectively on newborn patients at risk for developing DSH and correlation sought with umbilical cord blood values of insulin.